Chronic Kidney Disease in Children (CKiD)

PROJECT SUMMARY
The Chronic Kidney Disease in Children Study (CKiD) is a multi-center, prospective observational cohort study
of children aged 6 months to 16 years with mild to moderately impaired kidney function at study entry. Two
clinical coordinating centers (CCCs) at the Children’s Hospital of Philadelphia (CHOP), and Children's Mercy
Kansas City (CMH), and a data coordinating center (at Johns Hopkins Bloomberg School of Public Health) have
formed a cooperative agreement to conduct this study. Since its inception in 2003, the scientific aims of CKiD
have been to determine the risk factors for decline in kidney function and the effects of kidney function decline
on the risk factors for cardiovascular disease, growth failure and its associated morbidity, and neurocognitive
function and behavior. The purpose of this application is to request funds to continue the cohort study from
August, 2018 to July, 2023. The aims of the current proposal will expand on the original aims to include
completion of recruitment of 190 children with congenital anomalies of the kidney and urinary tract and other
non-glomerular kidney disorders early in the course of CKD, characterization of the impact of duration of CKD,
dialysis and kidney transplantation on the cumulative burden of cardiovascular risk factors, remote assessment
of physical activity and blood pressure, development of novel approaches to identify risk factors for CKD
progression, enhancement of research in childhood CKD through collaboration with other cohorts, and continued
provision of a broad data resource for the scientific community. The Principal Investigator of the East Coast
Coordinating Center has a long track record of NIH funding, clinical expertise in kidney disease in children,
methodologic expertise in clinical research design and analysis, experience with recruitment and retention,
quality control of study procedures, and organization of collaboration across the multiple participating sites in
CKiD. The CKiD study encompassess a geographically and racially diverse cohort. The structure of CKiD and
its support of ancillary studies continues to stimulate the generation of new knowledge pertaining to the
progression of CKD and the development and evolution of associated co-morbidities, as well as the publication
of those data. The infrastructure of CKiD continues to serve as a platform for career development awards for
junior investigators, and ancillary R01’s for more senior colleagues. Most importantly, with longer follow-up and
additional recruitment of subjects early in the course of CKD, we will continue to characterize novel biomarkers
of kidney injury that are associated with CKD progression and its sequellae to help inform future therapeutic
trials.

Public health relevance
PROJECT NARRATIVE The CKiD study is a landmark cohort study of children with CKD, having rallied 54 pediatric nephrology centers across the US and Canada to recruit and study over 900 children with mild to moderate CKD. From 2018 to 2023, the East Coast Coordinating Center (ECCC) will continue to coordinate the study visits in their CKiD participating sites, with the following long term goals: characterization of the impact of duration of CKD, dialysis and kidney transplantation on the cumulative burden of cardiovascular disease risk factors, development of novel approaches to identify risk factors for CKD progression, enhancement of research in childhood CKD through collaboration with other patient cohorts, and continued provision of a broad data resource for the scientific community. In the next phase of the CKiD study, the overarching goals will expand to include the study of children with CKD after initiation of dialysis or transplant, and the discernment of important sub-phenotypes of childhood CKD.